HDL Function in Human Disease

The central theme of our PPG is that HDL function is a critical determinant of atherogenesis and cardiovascular
risk in chronic human disease. The goal of our research is to define the mechanisms for HDL functional loss in
diseases associated with increased risk for atherosclerotic cardiovascular disease (ASCVD): Familial
Hypercholesterolemia (FH), Chronic Kidney Disease (CKD) and Rheumatoid Arthritis (RA). A major hypothesis
of the PPG is that dysfunctional HDL contributes to the residual inflammatory risk of cardiovascular events.
Reactive dicarbonyls including MDA, IsoLG, and ONE are highly reactive species that rapidly adduct to apoAI
and HDL phospholipids impairing HDL function. A major recent advance by our PPG is the discovery that two
different small molecule dicarbonyl scavengers, 2-HOBA and PPM, improve HDL function, reduce LDL oxidation,
and dramatically reduce atherosclerosis in Ldlr-/- deficient mice, a model of FH, in the absence of changes in
plasma lipid levels. The atherosclerotic lesions showed a dramatic decrease in necrosis and inflammation and
had evidence for reduced efferocytosis. Projects 1 and 4 will both explore the hypothesis that reactive carbonyl-
induced HDL dysfunction will impair macrophage efferocytosis. Project 1 will test the hypothesis that dicarbonyl
scavengers promote remodeling of established atherosclerosis with resolution of inflammation. These studies
will set the stage for a translational proof of concept study to test the hypothesis that the dicarbonyl scavenger
2-HOBA will inhibit modification of apoAI and HDL and improve HDL functions in humans with heterozygous FH
and subjects with CAD without FH. Interestingly, we have recently discovered that lipoproteins are highly-
enriched with small RNAs derived from bacterial and fungal species in the microbiome and environment
(msRNA). Another major theme is that msRNA carried by HDL influence HDL function and atherogenesis. Project
2 will examine the hypothesis that CKD increases mesenteric lymphatic output and apoAI harboring harmful
bioactive substances (IsoLG, miRNA, msRNA) that contribute to the increased risk of ASCVD. Importantly,
microbial sRNAs are present in human and mouse atherosclerotic lesions. Project 3 will examine the hypothesis
that HDL removes microbial sRNAs from lesion macrophages and suppresses pro-inflammatory gene
expression through retro-endocytosis and msRNA acceptance. In addition, we will target macrophage TLR7/8
activation in vivo using non-targeting locked-nucleic acids (ntLNA) to inhibit atherosclerosis progression and
promote regression. Project 4 will elucidate mechanisms whereby dicarbonyl modified lipoproteins potentiate
inflammation and cell death in macrophages and determine if these alterations contribute to reduced
efferocytosis. Overall, the proposed studies will advance our understanding of the role of HDL function in human
disease and identify new therapeutic approaches for the treatment of ASCVD. There are 4 Cores: Core A.
Administrative and Biostatistics; Core B Lipoprotein and HDL Function; Core C Chemical Synthesis and Lipid
Peroxidation Analytical Core; and Core D Non-Coding RNA and Bioinformatics.

Public health relevance
Narrative Overall Program The central theme of our PPG is that high-density lipoprotein (HDL) function is a critical determinant of atherosclerosis (plaque buildup in arteries) in chronic human diseases associated with increased risk of heart attack and stroke. Specifically, this Program will study diverse detrimental changes to HDL cargo and function, including 1) reactive dicarbonyl modifications to HDL lipids and proteins, 2) pro-inflammatory microbial small RNAs on HDL, and 3) molecular networks within a novel kidney-intestine-artery axis. In addition, we explore new therapeutic strategies to improve HDL function and reduce atherosclerosis using dicarbonyl scavengers and non-targeting locked-nucleic acids (ntLNA).